Research Training for Anesthetists

ABSTRACT
We seek to continue a postdoctoral research training program for anesthesiologists, now in its fortieth
year, in order to develop skilled physician-scientists who will expand knowledge and ultimately improve
clinical delivery of patient care in core practice areas of anesthesiology: perioperative medicine, critical
care, perinatal care, and pain management. We propose to offer ten carefully selected
anesthesiologists the opportunity to train with an outstanding investigator-mentor in one of the research
programs at the Harvard Medical School or its affiliated institutes and hospitals, for a period of 2 or 3
years. A national pool of candidates is recruited, with highly capable and motivated residents and
fellows at Harvard-affiliated academic anesthesiology programs providing an enriched source. Special
efforts are made to establish and maintain diversity through recruitment and retention of individuals
from underrepresented racial and ethnic groups, disabled individuals, and those from disadvantaged
backgrounds. The training program is structured as a tutorial, individualized to meet the specific needs
and research interests of each trainee. Research areas include, but are not limited to: biochemistry,
bioengineering, biophysics, clinical outcomes, endocrinology, epidemiology, genetics, metabolism,
molecular biology, neurobiology, pharmacology, physiology, and toxicology. To best match the needs of
trainees, faculty mentors are selected or recruited, based on their expertise and experience, funding
record, and demonstrated ability to help mentees succeed in achieving research independence,
including independent extramural support. Trainees will also undertake course-work tailored to their
individual experience, needs, and goals, which may include the completion of graduate certificates or
degrees. Training in responsible conduct of research will be required. The program’s long-term goal is
to increase the number of anesthesiologists with the knowledge, skills, and determination to become
independent researchers focused on questions of importance to anesthesiology and the basic sciences
upon which it rests. The participating Harvard-affiliated academic anesthesiology departments, in
which trainees will hold clinical appointments, are committed to their long-term career development
beyond completion of this program. These trainees are expected to enrich the next generation of
research leaders and mentors, as the needs of patients evolve and the medical discipline of
anesthesiology optimally responds.

Public health relevance
PROJECT NARRATIVE Anesthesiologists are medical specialists that lead care teams managing a wide range of patients undergoing invasive procedures, in critical care units, and suffering from pain. This project will train selected anesthesiologists to perform scientific research, so that they may become future leaders whose research efforts will improve the practice of anesthesiology, resulting in better patient care.